Characterization of the intact and defective HIV reservoirs in myeloid cells in the brain

PROJECT SUMMARY/ABSTRACT
HIV-1 cannot be eradicated by antiretroviral therapies alone. The major obstacle to eradicating HIV-1 is the
ability of integrated, replication competent viral DNA to persist latently in cellular reservoirs. Despite there being
a significant and extensive knowledge base regarding HIV-1 infection of the CNS and the development of
neurological disorders in HIV-1 infected viremic individuals, there is only a very limited understanding of the
mechanisms of persistence in the CNS following viral suppression. Despite some data supporting the CNS as
a potential reservoir of HIV-1 in virally suppressed individuals, there remains critical gaps in our knowledge
regarding the location, frequency and nature of viral persistence in the CNS. This data is critical to both
developing strategies aimed at the development of both a functional and/or sterilising cure. The goal of our
proposal is to characterise the persistent reservoir of HIV in the CNS, specifically the myeloid reservoir, and the
replication competence of the persistent virus.
The goals of this proposal, in response to the “Role of Myeloid Cells in Persistence and Eradication of HIV-1
Reservoirs from the Brain” RFA-MH-20-702 are to (i) use highly sensitive PCR based to quantify and characterise
the intact and defective HIV composing the myeloid reservoir in the CNS of virally suppressed patients, and (ii)
characterise the replication competence of the CNS myeloid reservoir. In Aim 1 we will use highly sensitive and
well established PCR assays, including the intact proviral DNA assay (IPDA) in conjunction with sensitive
immunohistochemistry and a modified laser microdissection technology to determine the quantity and
phenotypical location of the potentially intact HIV viral genomes CNS and non-CNS tissue from a cohort virally
suppressed individuals. We will determine the compartmentalisation of CNS derived genomes by comparison to
non-CNS tissues. In Aim 2, we will comprehensively characterise the replication competent nature of proviruses
from the myeloid CNS reservoir. Briefly, a subset of intact or defective proviruses isolated from myeloid cells of
the CNS of virally suppressed individuals (as determined by IPDA) will be confirmed by full-length individual
proviral sequencing (FLIPS) and cloned into expression vectors to characterise the replication competence in
both macrophage and T cells. Importantly, the ability of defective proviruses to continue to produce RNA and/or
neurotoxic proteins including tat and nef will be measured using retroviral vector systems or transfection.
We hypothesise based on our preliminary data that whilst the majority of proviruses in the myeloid CNS reservoir
will not generate infectious virions, a subset of proviruses will be replication competent. Furthermore, a subset
of defective proviruses will produce viral proteins. These data are essential to the development of HIV cure
strategies.

Public health relevance
PROJECT NARRATIVE Despite the success of antiretroviral therapy there remains no cure for HIV. The ability of the virus to 'hide' in an infected individual's tissues allows the virus to evade the immune system as well at the action of HIV drugs and establish 'silent' reservoirs of HIV. Our proposed study will define the size, location and nature of these reservoirs in the central nervous system; information critical to eradicating HIV.